Targeting PELP1 oncogenic functions in DNA repair for treating triple negative breast cancer

Breast cancer (BC), the most common cancer among military servicewomen than in the general population. This
makes BC a critical concern for female Veterans and VA health care. VA women has an increased risk of BC
due to service-related exposures. Women diagnosed with triple negative breast cancer (TNBC) have a more
aggressive clinical course, a higher propensity for metastases, and a worse outcome. Therefore, development
of novel therapeutic strategies represents a clear unmet need. Genome instability is a hallmark of cancer and
DNA replication represents one of the most vulnerable cellular processes that dysfunction therein leads to
genome instability in cancer cells. Topoisomerase inhibitors (TIs) are shown to enhance replication stress (RS),
and several TIs are approved by FDA for TNBC therapy. However, clinical utility is limited by toxicity and the
development of resistance. Therefore, understanding the molecular basis of RS and DNA repair will provide the
requisite foundation to develop new therapeutic targets and combination therapies. Proline-, glutamic acid-, and
leucine-rich protein 1 (PELP1) plays a critical role in TNBC progression. PELP1 status is a prognostic indicator
of poor BC survival. There is a major knowledge gap regarding the mechanisms by which PELP1 contribute to
cancer progression. We have developed a first-in-class inhibitor of PELP1 (SMIP34) that has activity on TNBCs
and preliminary studies suggested SMIP34 enhance the utility of TIs in treating TNBC. The Objective of this
proposal is to define the molecular mechanism of action of PELP1 in RS, DNA repair and to pave the path for a
novel combination therapy. Our overarching hypothesis is that PELP1 signaling in DNA repair represents an
attractive therapeutic target for SMIP34 in combination with TI in TNBC. In Aim 1, we will define the mechanisms
by which PELP1 promotes DNA repair, determine the role of PELP1 in RS mediated DNA damage and identify
PELP1 interactome under conditions of DNA damage. In Aim 2, we will characterize the role of PELP1
interactions with topoisomerases, establish the biological activity of SMIP34+TI combination therapy using
multiple TNBC models and determine the mechanisms by which SMIP34 enhances efficacy of topoisomerase
inhibitor. In Aim3, we will test the utility of SMIP34 + TI combination therapy in treating TNBC using orthotopic
xenograft models, determine its utility in reducing TNBC metastases and establish the translatability of SMIP34
+ TI therapy in treating TNBC using organoids (PDOs) and patient derived xenografts (PDX). This proposal
tests the novel concept that SMIP34 blocks oncogenic DNA repair pathways which plays a critical role in TNBC
progression leading to therapy resistance; and that disruption of PELP1 signaling with SMIP34 will enhance
therapeutic effect of currently FDA approved chemotherapy using TI. Successful completion of the proposed
studies will lead to the development of novel SMIP34+TI combination therapy that addresses the critical need of
targeting TNBC. This research program is significant as it is expected to establish a novel targeted therapy
critical to the treatment or prevention of TNBC in Veteran population.

Public health relevance
Among women Veterans, breast cancer (BC) is the most diagnosed cancer, accounting for 30% of female cancers and is more prevalent among older Veterans. Of great significance is the fact that BC is more common among military servicewomen, than in the general population. Further, this is particularly important for South Texas Veterans where BC prevalence is rampant. This research program is significant, as it will identify therapeutic targets and develop novel combination therapy for treating triple negative breast cancer (TNBC, a deadly subtype of BC). These treatments are urgently needed for many VA patients and will be a cost-effective approach with potential to save millions of dollars to the VA health care system.